Feature characteristics and signaling mechanisms involved in SGN neurite guidance by engineered topographical and biochemical micropatterns

Project Summary/Abstract
The cochlea exploits an intricate tonotopic organization of afferent innervation to effectively process highly
complex auditory stimuli. To create this precisely organized pattern, the neurites from spiral ganglion neurons
(SGNs) navigate a complex milieu of cells, extracellular matrix, and biochemical gradients to reach their
peripheral and central targets in the organ of Corti and cochlear nuclei, respectively. This process of a neurite
growing through the environment is called pathfinding. In pathfinding, the tip of the neurite, the growth cone,
senses, turns, and grows toward a target in response to biochemical and biophysical cues. This proposed
research focuses on understanding how different substrate cues (topography, chemoattractive, and
chemorepulsive) can promote an SGN neurite to turn as well as by which by signaling pathways a growth cone
relies on to execute this basic biological process.
Previous work has identified that engineered micropatterned substrates can be used to both (1) direct SGN
growth and (2) study the signaling pathways activated by this phenomenon in vitro. We have demonstrated that
neurons align their outgrowth to various engineered patterned substrates (topographical, chemoattractive, and
chemorepulstive). Additionally, we have implicated RhoA-GTPase and calcium signaling in SGNs aligning their
outgrowth to topographical cues. I propose to use this engineered micropatterned substrates to study (1) the
hierarchy and interaction of topographical and biochemical cues in dictating neurite turning and (2) the
biochemical pathways necessary for a growth cone to sense and turn in response to these cues. In particular, I
will study how chemoattractive (laminin) and chemorepulsive (EphA4) interact with topographical growth cues
when placed in complimentary (attractive in troughs) or antagonistic (repulsive in troughs) patterns. Additionally,
I will research the role of Rho/ROCK and IP3 signaling in this basic biological process using pharmacology and
imaging the activation of these pathways in real time when growing on various patterned substrates.
Overall, the goal of this research is to better understand the key, basic biological process of how an SGN neurite
senses and turns in response to substrate cues. I expect to contribute knowledge to this field by utilizing novel
3D combination micropatterned substrates, real time imaging approaches of the pathways of interest, and a
machine learning image sorting model to use an unbiased approach in assessing neurite behavior in response
to the micropatterned substrates. These novel insights will inform many aspects of SGN pathfinding through (1)
determining if similar fundamental signaling pathways are used by SGNs when turning in response to both
biophysical and biochemical cues, (2) clarifying the mechanisms of how the tonotopic organization of the cochlea
develops, and (3) though this is not directly a translationally aimed proposal, the findings will also further the goal
of inducing organized neurite growth into close proximity to a CI.

Public health relevance
Project Narrative In order to reach their targets, neurites of spiral ganglion neurons (SGNs) sense, turn, and grow toward a target in response to biochemical and biophysical cues in their environment in a process called pathfinding. The objective of this proposal is to elucidate how topographical and biochemical cues, alone and in combination, affect neurite turning and also study the role of Rho/ROCK and IP3 signaling in the basic mechanism of a neurite sensing and turning in response to these substrate cues. This project will inform the foundational developmental process of SGN neurite pathfinding as well as potentially lead to improvements in cochlear implants by better understanding how to direct their growth.